Visualizing oxidative stress using hyperpolarized magnetic resonance

PROJECT SUMMARY/ABSTRACT
Reactive oxygen species (ROS) are the byproduct of normal metabolism as well as the differential state and
environment of the cell. They lead to oxidative stress and can be the causes of multiple pathologies, including
cancer. Moreover, oxidative stress and the cell's ability to deal with it can play a major role in the treatment of
these diseases. However, current methods to quantify oxidative stress in vivo are severely lacking and to date
there is no routine method to non-invasively image redox or oxidative stress in humans.
A new platform, hyperpolarized MRI, has the potential to change the way we interrogate metabolism in vivo. We
and others have utilized the power of this approach, combined with endogenous substrates, to non-invasively
image a metabolic substrate and its subsequent downstream products using conventional MRI. In our preliminary
work, we have developed a novel approach to imaging oxidative stress using HP dehydroascorbate (HP DHA),
the oxidized form of vitamin C. Using HP DHA, we are able to image the in vivo generation of HP vitamin C and
utilize the cells' endogenous system to create a non-invasive redox measurement. Combining this with fast
spectroscopic imaging approaches provides a means of readily imaging redox in mice.
These exciting developments provide the basis for pursuing the objectives of this innovative proposal to utilize HP
DHA MRI to further quantify oxidative stress in vivo. Using HP DHA, we will develop a parameter for conversion to
Vitamin C in vivo that quantifies the amount of oxidative stress the cell is under using both acute generation of
ROS in the normal brain and models of murine brain tumors treated with radiation. In parallel, we will utilize what
we have recently learned about the physical chemistry of hyperpolarized probes to design a more robust and
better performing HP DHA. Finally, we will conduct the optimization and toxicology studies necessary to translate
HP DHA to humans, aiming to conduct the first-in-human studies of this approach.
It is the overarching goal of this proposal to use this novel approach in metabolic imaging and lay the foundation
for future metabolic imaging of oxidative stress in patients. This effort will also provide a means of non-invasively
monitoring treatment response that aims to increase oxidative stress, which could be readily integrated into
standard MRI.

Public health relevance
PROJECT NARRATIVE The overarching goal of the proposed research is to develop a new MRI technology for imaging oxidative stress: hyperpolarized dehydroascorbate (HP DHA) MRI. Oxidative stress is implicated in the pathogenesis of many diseases, including neurodegeneration and brain tumors, and there is an urgent need to develop more sensitive and specific imaging approaches to characterize it. We aim to develop HP DHA MRI and apply it to preclinical models of oxidative stress in the brain and brain tumors as well as optimize it for translation into humans. This work will facilitate future patient-specific treatment planning, as well as earlier assessment of response to therapy and the development of novel experimental strategies for cancer treatment.